Genetic and Transcriptomic Resilience in Chronic Obstructive Pulmonary Disease

PROJECT SUMMARY
I am an academic clinician scientist with a focus on the genetics of respiratory diseases. My overarching career
goal is to make an important contribution to the public health burden of chronic respiratory diseases. I aim to
become an independent investigator with the skill set to utilize integrative ‘omic techniques for the improved
biological understanding and clinical management of chronic obstructive pulmonary disease (COPD). The
proposed research combines my prior experience in genetics and transcriptomics with training in genetic
association, transcriptomic analyses, and machine learning, in order to better understand the variability in
COPD genetic risk. The hypothesis of this proposal is that there are genetic variants and transcriptomic
factors that are associated with resilience to COPD. This will be tested by leveraging existing data from
multiple well-phenotyped studies from the NHLBI TransOmics for Precision Medicine (TOPMed) program.
Specific Aims: (1) Identify genetic variation associated with resilience to COPD against a background of
elevated genetic risk; (2) Define clinical, imaging, and blood gene-expression features of COPD
resilience; and (3) Predict lung-tissue gene-expression profiles of COPD risk and resilience from blood
gene-expression data. The cutting-edge research plan utilizes innovative methodologies to characterize
genetic and transcriptomic resilience to COPD. It is accompanied by a training plan that will provide me with
the skills to complete the research aims and the experience to transition to an independent research career. I
plan to submit an R01 expanding upon the characterization of genetic and transcriptomic resilience in COPD
by combining multi-omic risk- and resilience-scoring and lung-tissue gene-expression imputation to improve
understanding of the biological mechanisms that contribute to observed clinical heterogeneity in COPD. In
particular, I have four training goals that build upon my existing background in respiratory genetics. (1)
Strengthen my knowledge of biostatistics, statistical genomics, and bioinformatic methods; (2) Expand
my skills in transcriptomic methodologies; (3) Gain experience and expertise in the development and
implementation of machine-learning algorithms; and (4) Further develop my mentoring skills and
understanding of study design. I am supported by a mentoring team with complementary skillsets and
successful mentoring careers, which, together with my experience, training, and substantial preliminary data,
will guarantee the success of this proposal. The findings may pave the way for the development of precision
risk-prediction approaches, while implementing a novel methodology to address one of the most important
challenges in the field today: identification of genetic and transcriptomic resilience to COPD.

Public health relevance
PROJECT NARRATIVE While some genes can increase the risk of disease, other genes may reduce the effect of these risk genes as well as the effect of environmental factors. In this study, we will identify genetic variants that contribute to resilience to chronic obstructive pulmonary disease (COPD) by attenuating the effects of genetic risk variants and cigarette smoking. This will result in greater understanding of the ways that genetic factors contribute to variable disease risk, and this information might be used to better predict risk for COPD and identify new treatments.